Pathogen Discovery in Emerging Infectious Diseases

Emerging and re-emerging pathogens such as HIV, prions, MRSA, XDR Tb, West Nile, hendra- and nipah, metapneumo-, calici-, hanta-, Ebola-, Marburg-, corona-, influenza-, chikungunya- and rhinoviruses, are sculpting a new landscape for public health and clinical medicine. This phenomenon has been ascribed to the destruction of natural habitats; political instability and poverty; climate change; the increased susceptibility to infection of an aging population or one immunosuppressed by HIV, cancer or transplantation; increasing population density; and inappropriate use of antibiotics. With globalization of travel and trade, microbes, vectors and reservoirs do not remain geographically discrete. Point source infections can rapidly become outbreaks or distribute even more broadly to become pandemics. Thus, clinicians and public health practitioners must be prepared for the appearance of new pathogens, new syndromes, as well as known syndromes due to known pathogens in new contexts. Classical culture techniques, immunohistochemistry, EM, and serology are vital in pathogen discovery as well as diagnostic clinical microbiology; nonetheless, molecular methods are increasingly employed due to speed, lower cost and the capacity to succeed in instances where fastidious requirements confound cultivation. We have established a staged strategy that enables rapid identification of emerging as well as known pathogens. This strategy will be used to investigate unexplained hemorrhagic fevers, unexplained encephalitis and meningoencephalitis, and unexplained febrile illness in

Public health relevance
Early and accurate differential diagnosis of infectious diseases is critical in clinical medicine and public health. The aims described here will enhance our ability to detect and rapidly characterize novel infectious agents, naturally emergent or deliberately engineered, and provide insights into unexplained acute infectious diseases. In so doing they will inform and focus investments in animal models, antivirals and antibiotics, therapeutic monoclonal antibodies and vaccines.